Center for Improving Care Delivery for the Aging (CICADA)

Project Summary – Analysis Core
The Analysis Core of the proposed renewal of Penn’s Center for Improving Care Delivery for the Aging
(CICADA) fosters rigorous inquiry in health services research (HSR) and related quantitative and qualitative
skill development by developing infrastructure to promote advances that improve the health, wellbeing,
function, and independence of older Americans, particularly minoritized older adults. The renewed Analysis
Core will build on its current focus on health economics and quantitative skills by adding new capacity in
qualitative, mixed methods, and implementation science approaches. These additions will expand our ability to
promote cutting-edge research methods that center the voices of patients and communities who have been
traditionally underserved in the health care system, in support of true transformation in health care delivery. It
will also equip Scientists with a full suite of HSR skills needed to understand and address complex, multilevel
contextual factors contributing to the health and wellbeing of older Americans. The Analysis Core lowers these
barriers to entry for new Scientists and CICADA Alumni by leveraging Penn’s unique resources. Providing
access to these resources enables RCMAR Scientists to develop into productive, independent, equity-
integrated investigators focused on aging. With these unparalleled resources, CICADA is able to recruit the
most talented researchers in the field from minoritized and underrepresented groups, for training and
mentorship to address the equity and health services issues confronting aging populations.
The Analysis Core has developed, supported, and maintained a CICADA research infrastructure of data
resources, analysis support, and methodological expertise that is easily accessible to RCMAR Scientists and
CICADA Alumni. To support this, our four Specific Aims are: (1) To support RCMAR Scientists with resources
for quantitative research including datasets for conducting high-quality, high-impact research on health care
delivery for aging populations, particularly minoritized older adults; access to skilled data analysts; and a high-
capacity, secure computing environment; (2) To provide RCMAR Scientists with resources for qualitative and
mixed methods research including data collection, transcription, analysis, and interpretation; (3) To train
RCMAR Scientists in the methodological skills necessary for independent careers in equity-integrated HSR,
through individualized mentorship and training in quantitative, qualitative, and mixed methods approaches that
are tailored to their research and career goals; (4) To extend Analysis Core consultation services to all
CICADA Alumni, to support their ongoing science related to improving health care delivery in aging and
strengthen the CICADA network.